Stress Regulated RNA Degradation in Cardiac Hypertrophy

PROJECT SUMMARY
Cardiovascular disease progression includes the changes occurring at both cellular and molecular levels. The
cardiac transcriptome remodeling, including both transcriptional and post-transcriptional regulation on mRNA
largely contributes to the transcriptome complexity within the myocardium. Comparing to transcriptional
regulation, the mRNA post-transcriptional regulation in heart remains understudied. Among the different RNA
post-transcriptional regulation mechanisms, regulated degradation is an important part in maintaining RNA
homeostasis. In our preliminary analysis, we have utilized a state-of-art sequencing approach- BRIC-Seq and
have identified a global shift of RNA stability in hypertrophic cardiomyocytes. The genes that have changed
stability include regulators for metabolism, inflammation, cardiac contractile function, and RNA processing.
Further, we have discovered a novel RNA stability regulating complex involving the canonical RNA degradation
helicase-Upf1 and a cardiac enriched RNA binding protein (RBP)-RBFox1c. Based on our extensive preliminary
analysis, we hypothesized that Upf1-RBFox1c mediates stress regulated mRNA degradation (SRRD) in heart-
while Upf1 serves as an RNA helicase for RNA degradation, RBFox1c provides target specificity by binding
directly with the mRNA 3’UTR as an RNA binding protein. This proposal will combine both modern molecular
sequencing technologies and mouse cardiac disease model to address the following specific aims: 1) Establish
the contribution of Upf1 in stress regulated mRNA degradation in cardiomyocytes 2) Determine the role of
RBFox1c in SRRD target specificity 3) Establish the functional significance of Upf1 mediated SRRD in cardiac
hypertrophy. We believe our proposal will unfold an important layer of gene regulation in heart with critical
implication in basic biology and yield novel insights on cardiac transcriptome remodeling where stress regulated
RNA degradation can specifically target subpopulation of mRNA under both physiological and pathological
conditions. Accomplishing the proposed study will also provide important evidence for the therapeutic potential
of Upf1-RBFox1c complex in cardiac disease treatment.

Public health relevance
PROJECT NARRATIVE Cardiac remodeling events during cardiovascular disease progression can occur at both cellular and molecular levels. At molecular level, RNA degradation is responsible to regulate 3-20% normal mRNA stability under various physiological and pathological conditions but remains poorly studied in the cardiac disease. In this proposal, we aim to identify the molecular players and regulatory mechanism for mRNA degradation in heart during pathological remodeling.